Boxer Training Program in Molecular and Translational Hematology

Project Summary/Abstract
The Boxer Training Program in Molecular and Translational Hematology is designed to prepare physicians
and postdoctoral scientists for independent, research-oriented careers in hematology. The program draws on
the research interests and expertise of 19 well-funded faculty members in the Departments of Pediatrics,
Internal Medicine, Pathology, Pharmacology, Cell and Developmental Biology, Molecular and Integrative
Physiology, and Biological Chemistry, the Life Sciences Institute and the Howard Hughes Medical Institute,
and the Schools of Engineering and Public Health at the University of Michigan. Active areas include molecular,
cellular, and translational research of: 1) the pathophysiology of the immune system; 2) normal and malignant
hematopoiesis; 3) hemostasis, thrombosis, and vascular biology; 4) blood and marrow transplantation; and 5)
erythrocyte physiology and disease. A Selection/Monitoring Committee will recruit MD, MD/PhD, and PhD
trainees with strong academic credentials who desire a scholarly career encompassing hematology teaching
and research. MD candidates will have had 3 years of house officer training in Pediatrics or Internal Medicine
and a year of clinical training in Pediatric or Adult Hematology/Oncology. PhD candidates will have a major
interest in hematology-related research. During the research phase of training, MD trainees are strongly
encouraged to participate in a two-month Postdoctoral Research Training Program in Cell and Molecular
Biology. Trainees then spend 2-3 years under supervision of a faculty mentor, developing expertise in posing
feasible scientific questions, acquiring skills to answer these questions, and critically evaluating data obtained.
During their research training, trainees are continuously mentored and evaluated semiannually by a Mentoring
Committee. Trainees present the results of their investigations, participate in discussions of data obtained by
their colleagues, and attend relevant research seminars and interact with faculty members in basic and
translational sciences. This program will fulfill a critical need to train the next generation of academic
hematologists who will bridge the gap between laboratory and clinical research.

Public health relevance
Project Narrative Hematologic diseases affect millions of individuals throughout the United States. The goal of this program is to train the next generation of investigators in academic hematology who will develop new diagnostics and therapeutics for patients with these disorders.